SWOG Network Group Operations Center of the NCTN

SWOG Network Group Operations Center of the NCI National Clinical Trials Network (NCTN)
NIH/NCI U10 CA180888 (PI: Blanke) 04/17/2014 - 02/28/2025
Role: Principal Investigator, SWOG Group Chair
SWOG is a research organization with over 6,000 cancer investigators distributed across over 1,000
academic and community sites throughout the U.S. Canada, Latin America, Korea, and Saudi Arabia. The
Group has a long history of conducting clinical trials that have changed standard of oncologic practice and
that have led to Food and Drug Administration approval of new anti-neoplastic agents. SWOG's mission is
to design, direct and participate in clinical trials that will result in effective prevention and treatment of
cancer, in the process improving quality of life and quality of survivorship for those with malignancies.